Interpreting coding/non-coding variants for congenital heart disease through gene regulatory networks

PROJECT SUMMARY
Most developmental defects remain unexplained by current genetic testing. A key challenge to the prevention
and treatment of congenital defects is to interpret the impact of genetic variants (especially those in non-coding
regions) and to understand their molecular mechanisms of action. Our long-term goal is to understand how
genetic variation contributes to congenital heart disease (CHD). We are motivated by observations that defects
in cell fate commitment during development cause CHD. Numerous human and mouse genetic studies have
shown that loss-of-function coding mutations in developmental transcription factors (TFs) cause CHD. Since TFs
drive gene regulatory networks (GRNs), CHD variants in TFs culminate in the dysregulation of cardiac genes
during development. In parallel, non-coding variants have also been linked to CHD. Many of these variants are
thought to modify the activity of transcriptional enhancers, especially those that control the expression of
developmental TFs and regulatory programs. Together, these studies motivate the need to interpret variant
function in the context of developmental regulatory networks. The objective of this proposal is to use cardiac
regulatory networks as a platform to understand CHD genes and variants (Figure 1). We will define cardiac
development networks (enhancer → TF → genes) and use this network to interpret the functions of coding TF
variants and non-coding enhancer variants (both patient-derived and those not yet observed). We hypothesize
that this systematic dissection of cardiac GRNs will enable the characterization of variants that impact
cardiomyocyte (CM) specification and contribute to CHD. Our rationale is that this knowledge will help define the
missing heritability of congenital abnormalities. We propose the following specific aims: (Aim 1) Define the
transcription factors and gene regulatory networks of human cardiac development; (Aim 2) Define and
characterize genetic variants regulating cardiac gene programs; (Aim 3) Characterize the impact of coding/non-
coding variants on molecular and cellular phenotypes. This proposal is innovative because it will use
experimentally-derived gene regulatory networks as a platform to interpret CHD genes and coding/non-coding
variants. We expect this resource to propel new research horizons. This proposal is significant because it will
expand our understanding of how genetic variants impact TF activity, the state of cardiac gene regulatory
networks, and lineage specification, which will enable the functional interpretation of known and novel variants
in CHD patients.

Public health relevance
PROJECT NARRATIVE Congenital heart disease (CHD) affects nearly 1% of all live births, yet a substantial proportion of cases remain unexplained by current clinical genetic testing. The proposed research is relevant to public health because understanding the genetic and molecular basis of congenital heart disease is ultimately expected to advance the capability to diagnose and treat this disease.